B7-H3 in prognosis and immunotherapy of pancreatic cancer

DESCRIPTION (provided by applicant): Pancreatic adenocarcinoma is the most lethal pancreatic tumor. Currently surgical resection is the only therapy which can provide a 5 year survival. However, less than 15% of patients diagnosed with pancreatic adenocarcinoma will be fortunate enough to undergo surgical resection. Even with a complete surgical resection and adjuvant chemotherapy the actual 5 year survival is only 12%. These clinical findings highlight the need of biomarkers to identify this small fraction of patients and develop alternative and innovative therapeutic strategies. To address these needs, this proposal will test the hypothesis that the expression level of the costimulatory molecule B7-H3 in primary pancreatic carcinoma lesions correlates with clinical response to combinatorial surgery and adjuvant therapy, and that a tumor-restricted determinant of B7-H3 represents an appropriate target to apply antibody-based immunotherapy for this disease. This hypothesis stems from the following lines of evidence in the literature and our own results: i) the level of B7-H3 expression in hypopharyngeal carcinoma, non-small-lung carcinoma, renal cell carcinoma and prostate carcinoma is associated with the clinical course of the disease, ii) the B7-H3-specific mAb 376.96, generated in our laboratory, recognizes a determinant which is expressed with high frequency on malignant human tumor cells, including pancreatic carcinoma cell lines and surgically removed pancreatic carcinoma lesions, but has a very restricted distribution in normal tissues, and iii) mAb 376.96 mediates cell dependent cytotoxicity of human malignant tumor cells in antibody dependent cell-mediated cytotoxicity (ADCC) assays. To this end, we will measure the B7-H3 expression level in primary pancreatic carcinoma lesions with well- defined clinical information and correlate the results of this immunohistochemical analysis with the clinical responses. Furthermore, we will test the hypothesis that the extent of lysis and the anti-tumor effects mediated by mAb 376.96, like those mediated by other tumor antigen-specific mAb, such as CD20- EGFR- and HER2- specific mAb, are influenced by the polymorphism of the Fcγ receptor, FcγRIIIa, expressed by NK cells. The latter are the main effector cells. The information resulting from these studies will i) contribute to define the clinical significance of B7-H3 expression levels in primary pancreatic carcinoma lesions, and ii) represent a useful background to design antibody-based immunotherapeutic strategies to be tested in phase I trials in patients with pancreatic adenocarcinoma.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is an urgent need not only for effective therapeutic strategies to improve pancreatic adenocarcinoma patients' survival, but also for biomarkers to identify patients who are likely to benefit from the combination of surgical and adjuvant chemotherapy. To address these needs, this proposal will test the hypothesis that B7-H3, a member of the B7 immune costimulatory molecule family, represents a novel prognostic biomarker and a valid target to apply antibody-based immunotherapy in patients with pancreatic adenocarcinoma. Narrative There is an urgent need not only for effective therapeutic strategies to improve pancreatic adenocarcinoma patients' survival, but also for biomarkers to identify patients who are likely to benefit from the combination of surgical and adjuvant chemotherapy. To address these needs, this proposal will test the hypothesis that B7-H3, a member of the B7 immune costimulatory molecule family, represents a novel prognostic biomarker and a valid target to apply antibody-based immunotherapy in patients with pancreatic adenocarcinoma. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Pancreatic adenocarcinoma is the most lethal pancreatic tumor. This increasingly common tumor is derived from the ductal cells of the exocrine pancreas. The American Cancer Society predicts 37,680 new cases and 34,290 deaths from pancreatic adenocarcinoma in 2008. Currently surgical resection is the only therapy which can provide a 5 year survival. However, less than 15% of patients diagnosed with pancreatic adenocarcinoma will be fortunate enough to undergo surgical resection. Currently the only effective adjuvant therapy after surgical resection is chemotherapy using gemcitabine. Even with a complete surgical resection and adjuvant chemotherapy the actual 5 year survival is only 12%. Unfortunately, the majority of patients succumb to their disease within 20-24 months. It is unclear how the patients who survive 5 years are different from those who succumb to the disease within 20-24 months. For these reasons, there is an urgent need to identify novel biomarkers to distinguish patients who are likely to respond from those who do not, and targets to apply novel therapeutic strategies to improve survival. Among the latter, immunotherapy has been attracting much attention recently. The identification of clinically -relevant tumor antigens (TA) suitable for targeting with immunological effector mechanisms, the availability of highly specific humoral and cellular probes and the development of approaches to modulate the immune system have considerably enhanced the significance of immunotherapy as a promising anti-cancer strategy. The convincing clinical efficacy of monoclonal antibody (mAb)-based immunotherapy in patients with lymphoma and with various types of solid tumors has stimulated the development of antibody-based approaches for treatment of malignant diseases. In this vein, and taking advantage of our preliminary evidence, we propose to investigate the anti-tumor effects in pancreatic carcinoma of the mAb 376.96, specific for a tumor restricted determinant of the co-stimulatory molecule B7-H3, and the role of the polymorphism of the Fcγ receptor, FcγRIIIa, expressed by NK cells in these effects. Furthermore, we plan to test the usefulness of B7- H3 as a prognostic biomarker in this disease. The rationale underlying our work is provided by the following lines of evidence in the literature and our own results: i) the level of B7-H3 expression in human solid tumors, such as non-small-cell lung , renal cell , prostate and hypopharyngeal carcinoma, is associated with the clinical course of the disease, increasing significantly in advanced disease stages, ii) the B7-H3-specific mAb 376.96, generated in our laboratory recognizes a determinant which is expressed on human malignant cells, including pancreatic carcinoma cell lines and surgically removed pancreatic carcinoma lesions, but has a very restricted distribution in normal tissues, iii) in vitro, mAb 376.96 mediates antibody-dependent cell-mediated (ADCC) lysis of human malignant tumor cells and iv) the extent of cell dependent-lysis of tumor cells mediated by TA-specific mAb, such as CD20-, EGFR- and HER2-specific mAbs, is influenced by several variables, most notably the polymorphism of the Fcγ receptor, FcγRIIIa, expressed by NK cells, which are the main effectors of ADCC. Therefore, the Specific Aims of this proposal will test the hypothesis that: i) the expression level of B7-H3 in primary pancreatic carcinoma lesions is associated with the clinical course of the disease, and with the clinical response to the combination of surgical and adjuvant therapy. ii) the extent of ADCC of pancreatic carcinoma cells in vitro and the in vivo anti-tumor effects mediated by the chimeric mAb 376.96 are influenced by the codon 158 polymorphism of FcγRIIIa expressed by NK cells. To facilitate the translation of the data generated in vitro and in a mouse model system to a clinical setting, we will perform our studies using a recombinant chimeric 376.96 mAb suitable for clinical use. The generation of this reagent is funded independently of this proposal. The information derived from the outlined studies will: i) contribute to defining the clinical significance of B7-H3 in pancreatic carcinoma and ii) represent a necessary requirement for the design of future antibody- based immunotherapeutic strategies to be tested in phase I trials in patients with pancreatic carcinoma.